Dietary regulation of inflammasome-mediated host defense by branched-chain amino acid metabolism

PROJECT SUMMARY/ABSTRACT
Respiratory infectious diseases including pneumonia are an immediate public threat to the USA and global
healthcare systems. We must gain a deeper understanding of the innate immune system’s response to
pulmonary pathogens in order to develop host-directed therapeutic approaches that combat infections in the
lung. To this end, my lab studies innate immune mechanisms of defense against the bacterial pathogen
Legionella pneumophila (Lp), an important cause of community- and hospital-acquired pneumonia. Effective host
defense against Lp is driven by a class of inflammasome-assembling innate immune sensor proteins, which
detect bacterial motifs to trigger an inflammatory form of cell death termed pyroptosis. By driving the production
of inflammatory interleukin (IL)-1 cytokines and restricting the replicative niche for intracellular bacterial
pathogens, inflammasomes promote host protection against a broad array of respiratory infectious diseases.
Despite this knowledge, achieving a mechanistic understanding of the specific dietary factors and metabolic
signaling events that license inflammasome function to drive antimicrobial defense remains an overlooked – and
yet critically important – arm of host immunity. To fill this gap in understanding, I study the branched-chain amino
acids (BCAAs), a physiologically abundant and dietarily tunable (i.e., essential) class of amino acids that have
important metabolic properties. In addition to catabolically supporting oxidative energy production, the BCAAs
are key factors that drive cellular anabolic signaling mediated by mammalian target of rapamycin complex 1
(mTORC1) and metabolic stress adaptation orchestrated by the integrated stress response (ISR). As such, the
disparate nodes of BCAA metabolism and sensing integrate to selectively shape transcriptional and translational
processes in the cell. Despite this knowledge, a mechanistic understanding of the pulmonary host defense
functions of the BCAAs remains unknown. This scientific question motivates my studies proposed herein. I have
generated preliminary data demonstrating that the BCAAs promote IL-1 cytokine production and broadly license
diverse triggers of inflammasome-mediated pyroptotic cell death in macrophages. These findings therefore
provoke the conceptually novel hypothesis that the coordinated sensing of the BCAAs through mTORC1
and the ISR transcriptionally and translationally supports inflammasome-driven host defense against
respiratory bacterial pathogens. In Aim 1, I will mechanistically dissect how BCAA catabolism and sensing
converge to transcriptionally and translationally drive inflammasome function and IL-1 release. In Aim 2, I will
determine if and how the BCAAs are required for inflammasome-driven restriction of Lp in vitro and in vivo. The
major scientific goal of this fellowship is to unveil a novel role for essential nutrient sensing in functionally tuning
inflammasome-mediated defense against pulmonary pathogens. Another goal is to advance my training in
preparation for a career in leading my own independent research group. The strong mentorship of Dr. Sunny
Shin and exceptional research environment at Penn will ensure successful completion of this fellowship.

Public health relevance
PROJECT NARRATIVE We must gain deeper insights into how our immune system responds to pulmonary bacterial pathogens, as this will enable us to develop host-directed therapeutic approaches that better treat respiratory infectious illnesses like pneumonia. Studies in this proposal will address a major gap in our understanding of how essential amino acid components of the diet instruct inflammatory mechanisms of immune cell death to defend us against bacterial infection in the lung. As inflammatory cell death is a host-protective strategy employed by our immune system against a diverse array of pathogens, it is thus of broad public health importance to mechanistically understand how nutritional factors regulate this immune function to prevent infectious disease.